Distributed synaptic plasticity in fear conditioning

DESCRIPTION (provided by applicant): The formation of normal long-term memory (LTM) requires alterations in gene expression and protein synthesis in neurons. These changes are critical for modifications in synaptic function and proceed through a time dependent consolidation process after training. Recent evidence strongly suggests that when a stable LTM is later recalled and moves into an active state, the neural substrate for this memory requires a period of reconsolidation that depends on some of the same cellular processes involved in initial memory formation. This project addresses the importance of two cellular processes in the formation and stability of memory: protein translation controlled by the mammalian target of rapamycin (mTOR) pathway, and protein degradation through the ubiquitin-proteosome system. We use Pavlovian fear conditioning in rodents as an established model system in which several brain structures critical for memory formation and storage have been identified. Using quantitative protein assays we will measure the activity of mTOR and related molecular targets at multiple behaviorally relevant brain sites during the formation and retrieval of LTM and test a series of specific hypotheses about the role of this translational control pathway in learning. We will also assess the importance of protein degradation in the formation and stability of memory and begin to analyze the interactions between activity dependent synthesis of new synaptic protein and its targeted degradation. The results should provide important new insights regarding the neurobiology of memory and the molecular events that underlie learning. These finding may help to identify important new therapeutic targets in the treatment of memory and anxiety disorders.

Public health relevance
Project narrative This project addresses basic neurobiological questions about the formation and storage of long-term memory. The cellular mechanisms to be addressed here are and have little attention in whole animal studies and may form the basis for important new treatments for memory disorders, age related memory impairment, and diseases that affect synaptic plasticity and cognitive function. A better understanding of how fear memory is stored will also improve therapeutic approaches to anxiety disorders such as PTSD and phobias.